Breast cancer neoadjuvant endocrine therapy during the Covid-19 pandemic: Opportunity for a new treatment paradigm?

Neoadjuvant endocrine therapy (NET; pre-surgical treatment with an anti-endocrine drug) has been suggested
as a promising support system for addressing surgical delays among breast cancer patients, but a better
understanding of the impact of NET among a broad cross-section of patients is needed before it can be
integrated into usual care. Surgery is a standard treatment for breast cancer, but up to 36% of patients in the
US do not receive surgery within the recommended time period. Delaying surgery by >6 weeks has been
associated with an 82% relative increase in breast cancer death, thus bridging this gap in care with
alternative treatments such as NET may substantially improve survival among this subset of patients.
NET produces similar rates of clinical and radiologic response when compared with the more commonly used
neoadjuvant chemotherapy and has strong potential as a treatment for patients with hormone receptor-positive
(HR+) breast cancer, particularly those who are not expected to derive any benefit from chemotherapy. NET
was rare (~3% of stage II-III HR+) before the COVID-19 pandemic, and was generally reserved for patients
needing cytoreduction prior to surgery. As such, most prior studies evaluating the relationship between the
NET and treatment endpoints, such cellular proliferation (i.e., Ki-67 expression), tumor size, estrogen receptor,
and nodal status, over-represented patients with large tumors and a later stage at diagnosis. There are few
data to address whether NET-associated changes to prognostic factors observed in past studies can
be generalized to the broader population of patients with HR+ breast cancer, including those with the
smaller and earlier stage tumors that are characteristic of HR+ disease. Therefore, the objective of this study
is to evaluate the prognostic impact of NET in a non-clinical trial population of 155 patients with HR+ breast
cancer who were treated in the University of North Carolina Health system during the Covid-19 pandemic,
including those with early stage disease. Our underlying hypothesis is that patients will experience a positive
response to NET treatment, but that the magnitude of the response will vary by demographic and
socioeconomic characteristics. Using a within-person design (pre-/post-NET comparison), we will (Aim 1)
quantify the effect of NET on Ki-67, radiologic tumor size, estrogen receptor expression [%], nodal status, and
the composite pre-operative prognostic index (PEPI); and (Aim 2) identify individual-level and structural factors
that are associated with NET response (i.e., change in the prognostic factors described in Aim 1). Timely
access to surgical care is not always feasible. The development of alternative treatment strategies that mitigate
the effects of surgical delays may reduce the risks of greater breast cancer morbidity while long-term solutions
are developed. The proposed study will help fill this gap by demonstrating the real-world effects of NET in a
general population of patients with HR+ breast cancer.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will provide crucial information about the potential benefits of neoadjuvant endocrine treatment in a subgroup of breast cancer patients not previously considered for this type of therapy. This is in line with the NCI’s mission to develop knowledge that can be used to lessen the burden of cancer in the US and around the world.